Consequences of gain-of-function RPA1 mutations on telomere function and hematopoiesis

Project Summary
Inherited mutations in genes governing telomere maintenance cause Telomere biology disorders (TBD), a group
of diseases with a progressive course and poor prognosis characterized by pulmonary fibrosis, liver cirrhosis,
and bone marrow failure (BMF). Understanding the molecular mechanisms governing telomere preservation and
identifying TBD associated genes are established gaps. We recently published novel germline heterozygous
missense variants in RPA1 in four unrelated probands presenting with TBD. We also demonstrated that RPA1
mutants have elevated affinity to random and telomere single strand DNA, which causes a unique gain-of-
function (GoF) effect, defective hematopoiesis due to short telomeres in RPA1 mutant iPSC cells and extensive
somatic rescue mosaicism. The molecular mechanism through which RPA1 GoF mutations cause telomere
shortening, and TBD is unknown. I hypothesize that RPA1 mutations cause TBD by outcompeting essential
telomere maintenance proteins for binding to ssDNA, thereby limiting stem cell replicative potential. The
proposed studies will investigate these questions through two specific aims: 1) determine the molecular
mechanism by which GoF RPA1E240K causes telomere dysfunction and 2) determine the effect of RPA1E240K on
telomere maintenance and hematopoiesis in vivo.
A Mentored Clinical Scientist Research Career Development Award (K08) will provide the candidate with the
amount of protected time needed to achieve her career goal of independence as a physician scientist and focus
on improving the clinical outcomes of patients with BMF and DNA repair disorders through understanding the
mechanisms of their disease pathogenesis. A strong career development plan including experienced and
successful faculty advisor and co-advisor committee, clear plans for progress assessments, and attendance at
numerous courses, lectures, and workshops to increase proficiency in technical and management skills will
accompany these research goals to ensure success as an independent physician scientist. This award will be
completed at St. Jude Children’s Research Hospital (SJCRH), one of the world’s leading academic institutions
focused on the research and treatment of pediatric catastrophic diseases, making it an exemplary location for
an early career physician scientist to develop his career. In addition to the strong institutional support, St. Jude
offers unmatched research support with facilities including the Flow Cytometry and Cell Sorting Shared
Resource, Center for Advanced Genome Engineering (CAGE), Light Microscopy Division of Cell and Tissue
Imaging Center, Animal Resource Center, Cytogenetics Core, and Center for Proteomics.

Public health relevance
Project Narrative We have recently associated telomere biology disorders (TBD) and gain-of-function germline RPA1 mutations. The molecular and functional consequences of these mutations on telomere maintenance and hematopoiesis is not understood. The proposed studies will use biochemical methods and iPSC disease model to establish the molecular mechanism by which gain-of-function RPA1 mutations cause telomere dysfunction while using in vivo murine system to determine the functional consequence.